INTERACTION OF MESENCHYMAL AND MYELOID FIBROBLASTS IN INFLAMMATORY-BASED FIBROSIS IN THE AGING HEART

PROJECT SUMMARY
In 2030, elderly people will represent 20% of the US population. The focus of our work is on the mechanism(s)
causing fibrosis and diastolic dysfunction, which has become epidemic in the aging population. Our overall
objective is to examine cellular and molecular interactions between fibroblasts of two developmental origins
(mesenchymal and myeloid) and potential rescue approaches to reduce diastolic dysfunction and cardiac fibrosis
in the aging heart. The central hypothesis arose from our data in which we identified the signaling abnormalities
in mesenchymal fibroblasts that directly contribute to their aberrant activation resulting in fibrosis and stimulation
of monocyte influx into the heart. Infiltrating monocytes polarize into myeloid fibroblasts and further contribute to
mesenchymal fibroblast pathological activation. To examine the contribution of each fibroblast type and their
interaction, we will use specific inhibitors such as 1) AICAR, an AMPK activator that inhibits the pathologically
upregulated Erk pathway in mesenchymal fibroblasts and thereby reduces collagen and fibronectin levels in the
aging heart and 2) DCSL-1, which specifically binds to DC-SIGN, a receptor found exclusively in leukocytes. We
have found that in vivo DCSL-1 treatment improves cardiac function and decreases the number of M1
proinflammatory macrophages and myeloid fibroblasts in the heart as well as reducing collagen deposition. In
SA1, we will determine the mechanism by which defective mesenchymal fibroblasts contribute to interstitial
fibrosis in the aging heart and examine the role of an AMPK activator in reversing these defects. We will examine
the molecular mechanism by which pathological matrix deposition occurs in aged mouse and human tissues
using electron microscopy, mass spectrometry and signaling pathway activation analyses. We will also
determine the impact of in vivo and in vitro AICAR on these processes. Finally, the changes in cardiac fibrosis
and function after in vivo AICAR treatment in mice will be monitored by noninvasive MRI, Echo and Doppler
measurements. In SA2, we will investigate the role of the inflammatory infiltrate in fibrosis and in the altered
mesenchymal fibroblast phenotype by use of a myeloid-specific inhibitor, DCSL1. We will compare aged mice
treated with DCSL-1 with age-matching controls and study infiltrating leukocytes via noninvasive cell tracking
using MRI, analyze infiltrating monocytes and lymphocytes via mass cytometry and identify cytokines secreted
by them via protein array. Furthermore, the role of DCSL-1 on T lymphocyte populations will be investigated
using adoptive transfer. For in vitro studies the effect of secreted cytokines on mesenchymal fibroblasts of mouse
and human origin will be analyzed as well. Finally, matrix analysis and cardiac function study to compare DCSL-
1 and control treated aged mice will be done as in SA1. This approach is innovative and significant because it
will allow us to link changes in cardiac function to molecular and cellular responses. Furthermore, our Preliminary
Data shows a correlation of the mouse model with the human aging heart, where we observed the same defects.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because the identification of molecular and cellular changes that are associated with aberrant fibrosis in the aging heart. The proposed application is relevant to the part of NIA's mission that relates to understanding of the nature of aging and aging processes.